Determining the role of Rac1 palmitoylation in cardiac hypertrophy and oxidative stress

PROJECT SUMMARY
Cardiovascular disease, including heart failure, is the leading cause of mortality in the USA and new therapeutics
are needed to better treat these diseases. Cardiac hypertrophy is the process by which the heart becomes larger
in response to an increased workload and although initially adaptive, this often leads to maladaptive cardiac
remodeling and is involved in the pathogenesis of several cardiac diseases. Rac1, a Rho family small GTPase,
is required for the development of cardiac hypertrophy and relatedly plays an important role in mediating
oxidative stress in the heart as a regulatory subunit of the NAPDH oxidase 2 (Nox2) enzyme complex. Both
hypertrophy and oxidative stress promote the progression of heart failure and therefore determining novel
regulatory mechanisms controlling these processes is of great interest to the pharmaceutical industry. Rac1 is
palmitoylated at Cys-178 which promotes its activation and membrane targeting. Palmitoylation is a reversible
post-translational lipid modification that dynamically regulates protein signaling and has been shown to be
required for pathologic signaling in several disease states. Importantly, both genetic and small molecule
strategies have been effectively utilized to target palmitoylation of specific proteins in pre-clinical models of
diseases such as cancer and inflammation. However, the role of palmitoylation in regulating pathologic signaling
in the heart remains untested. Excitingly, our preliminary data demonstrate that genetic inhibition of Rac1
palmitoylation protects neonatal rat cardiomyocytes, a common in vitro model of cardiac disease, from both
hypertrophy and oxidative stress induced by hyperactive Rac1 signaling. Therefore, we hypothesize that
palmitoylation of Rac1 at Cys-178 targets Rac1 to the membrane where it is activated and induces pathogenic
signaling in part through regulation of the Nox2 complex. This proposal seeks to determine the function of Rac1
palmitoylation in regulating cardiac hypertrophy and oxidative stress in vivo using two relevant models of cardiac
hypertrophy. We will use a chronic AngII infusion model of cardiac hypertrophy as well as a model using AAV-
mediated overexpression of constitutively active Rac1, which causes dilated cardiomyopathy. In these models,
we will test the effect of mutating Cys-178 to serine (C178S) which cannot be palmitoylated to rigorously
determine the necessity of palmitoylation for the development of cardiac hypertrophy and myocardial oxidative
stress. The results of this work will test, for the first time, a role for palmitoylation-dependent signaling in
regulating the progression to heart failure. This fellowship will provide me with the training necessary to succeed
as an independent scientist in the pharmaceutical industry as well as make significant contributions to our shared
scientific knowledge that have the potential to improve human health.

Public health relevance
PROJECT NARRATIVE Cardiac hypertrophy and myocardial oxidative stress are two major drivers of heart failure progression and both processes require the activity of Rac1, a small GTPase. Rac1 is known to undergo palmitoylation, a post- translational lipid modification that influences protein activity and localization, however the ability of this modification to control Rac1 signaling in the heart remains untested. This proposal seeks to determine the role of Rac1 palmitoylation in regulating cardiac hypertrophy and oxidative stress using both in vitro and in vivo approaches, thereby testing a novel regulatory mechanism of pathologic cardiac signaling that could potentially be targeted for the treatment of heart failure.